Microbiology Track III - Animal Food Product Testing

Animal Food Micro Project Abstract Tennessee Department of Agriculture's (TDA) goal within this project to contribute further to an integrated animal feed and food safety system across the United States. This project will be used to analyze samples, support project staff, and further training across Technical Services Laboratory.

Public health relevance
Microbiology Animal Food Product Testing Project Narrative Tennessee Department of Agriculture (TDA) plans to collect no fewer than 100 animal food/feed samples for microbiological analysis. This goal will be accomplished by TDA leveraging existing resources within the Agriculture Inputs section as well as the Technical Services Laboratory (TSL). During this project period TSL will maintain its ISO 17025 accreditation under this track.